Testing a Biosocial Model of Borderline Personality Features in Youth

Project Summary
Gender diverse youth assigned female at birth (AFAB) experience high rates of suicide-related behavior,
including suicidal ideation, suicide attempts, and non-suicidal self-injury that are associated with long-term and
costly treatment, inpatient hospitalizations, and emergency room visits. Yet very little is known about
mechanisms underlying the profound risk for suicide among gender diverse youth AFAB, hindering efforts to
address the personal and societal burden associated with suicide in this vulnerable population. The need to
belong is central to prominent models of suicide, and failure to acquire close, reciprocal relationships is posited
to beget suicide-related behaviors. As many gender diverse youth AFAB report profound loneliness, the NIMH
RDoC Social Processes construct of Attachment and Affiliation may be of primary relevance to understanding
the emergence of suicide-related behavior. Attachment and Affiliation deficits, namely heightened sensitivity to
peer rejection cues and blunted responses to peer acceptance cues, have been associated with difficulties
forming and maintaining relationships with others and have also been associated with risk for suicide-related
behaviors. However, most work has relied on self-report measures of social processing, which may be limited in
detecting the precise deficits involved in social processing. A priori prospective research examining neural
alterations in social processing is needed to clarify the pathway through which Attachment and Affiliation deficits
beget suicide-related behavior. Indeed, emerging research suggests gender diverse youth AFAB have
particularly high rates of social dysfunction and suicide-related behavior compared to other sexual and gender
minority youth groups. In response to NOT-OD-22-030, we seek to critically examine gender diversity using
developmentally sensitive measures, including felt-gender, gender noncontentedness, and gender
nonconformity, in a clinically diverse sample of 180 early adolescent youth AFAB (10-14 years old) recruited
from R21 MH125052 and R21 MH124027. Neural alterations in processing of peer rejection and acceptance
cues will be tested as mechanisms underlying the emergence of suicide-related behavior measured one year
later in gender diverse youth AFAB. Parent and peer risk and resilience factors will also be explored. It is
anticipated that findings from this work will clarify targets for intervention and direct efforts to mitigate risk for
suicide-related behaviors in gender diverse youth AFAB.

Public health relevance
PROJECT NARRATIVE Gender diverse youth assigned female at birth (AFAB) experience high rates of suicide-related behavior, including suicidal ideation, suicide attempts, and non-suicidal self-injury, although very little is known about the mechanisms underlying the risk for suicide-related behavior in this vulnerable population. In response to NOT- OD-22-030, we propose to conduct a comprehensive assessment of gender identity in a clinically diverse sample of youth AFAB (n=180) from R21 MH125052 and R21 MH124027 in order to test neural alterations in social processing as potential markers of suicide-related behavior among gender diverse youth AFAB. Findings will provide important preliminary data to guide preventative efforts to mitigate the personal and societal burden of suicide-related behaviors among gender diverse youth AFAB.